SUPPORT SERVICES FOR EPIDEMIOLOGIC STUDIES

The Epidemiology Branch of the National Institute of Environmental Health Sciences has entered into a contractual agreement with Survey Research Associates, Inc. (SRA) to obtain support services for epidemiologic studies carried out by branch scientists. The contractor is responsible for providing services such as but not limited to, forms design, data collection by telephone or personal interview, collection and transport of biologic specimens, coding, medical abstraction, and computer services. In order to provide complete computer services SRA has entered into a subcontract with Westat, Inc. Study coordinators at SRA are responsible for the day to day management of all studies carried out in the Epidemiology Branch. Through the use of subcontracts the contractor can also arrange the laboratory analyses, industrial hygiene services or other services as dictated by the needs of individual projects.